Administrative Core

The Administrative Core will coordinate efforts between the Projects and Large Animal and
Microscopy Cores. Successful execution of the three projects that comprise this P01 are
necessary to test the central hypothesis. Quantification of neocortical network structure (Project
2) and Cl-i and Cl-o (Project 3) must be measured as a function of time after brain injury and
epileptogenesis (Project 1). These projects all utilize the same experimental cohort in order to
reduce costs and animal usage. Thus close coordination among the projects is essential.
Coordination of projects by the Administrative Core greatly facilitates simultaneous data
collection and analysis on the same animals. Experiments and animal enrollment are staggered
across the duration of the grant to minimize space requirements in the vivarium and operating
room and maximize the efficient, continuous utilization of space and personnel.
The Administrative Core will coordinate project meetings. Investigators currently meet monthly
to review results of Phase I of this project (tool development). We plan to continue these
monthly meetings to review progress, address problems, and coordinate research schedules.
Coordination by the Administrative Core is described in this section of the proposal.
The Administrative core will facilitate the interface of the P01 with external scientists and
organizations. In addition to monthly meetings of projects and cores, the Administrative Core
will also organize quarterly meetings with the investigators, consultants and the steering
committee. At these meetings, the overall direction of the research will be reviewed,
manuscripts will be discussed, and presentations at national and international meetings will be
addressed.
The administrative core will facilitate policy management and the execution of both internal and
institutional policies relevant to the project.
The administrative core will manage data transfer between projects, data archiving, and access
to the data by external investigators.
The Administrative Core will coordinate interactions with regulatory agencies, vendors, and
professional organizations.